Integration of visual information and behavioral modulation in the superior colliculus

PROJECT SUMMARY (See instructions):
Distinct visual features are extracted in parallel to be later combined and modulated along the visual
pathways. Two parallel pathways can be found early on, with projections from the retina targeting the
dorsal lateral geniculate nucleus, which targets cortical areas, and the superior colliculus (SC), which
projects to the pulvinar among other structures. These two pathways are often referred to as the primary
and the secondary pathway respectively and are inter-connected, notably at the level of the SC.
Importantly, visual inputs in the SC converge onto one morphologically and molecularly defined cell type:
the wide-field vertical cells (WFV). WFV cells dendritic arborizations sample a large part of the visual field
and we have recently shown that these cells are modulated by locomotion and receive inputs from multiple
brain region. Their morphology and projection to the pulvinar are conserved across species. These
observations place WFV cells as key integrators of visual and non-visual information.
To understand how WFV cells integrate information, the investigator will perform causal experiments in
which different sources of inputs will be manipulated in mice (Mus musculus) while the activity of WFV cells
will be assessed using calcium imaging. This will be followed by the identification of the connectivity of the
WFV in another animal model, the tree shrew (Tupaia belangerii), which is highly visual and closely related
to primates. This will address the conservation of the brain-wide circuit across species, thus opening new
alleys for translational work. To resolve existing discrepancy concerning the overall visual responses in the
SC, the visual responses of WFV cells will be characterized in tree shrews. This particular cell-type will be
isolated using an optogenetic approach and electrophysiological recordings, thus allowing for the
characterization of visual response preference of these cells. This project will yield compelling results
regarding the integration of visual information across the visual system, allow a direct comparison of the
same defined cell-type across two species, and reveal how internal states shape visual responses in the
SC.

Public health relevance
RELEVANCE (See instructions): Altered sensory processing is the hallmark of most psychiatric conditions, from schizophrenia to autism, but to this date, it remains unknown how sensory information is processed in the brain and to which extend perception is influenced by our emotional state. By studying how visual information is integrated and shaped by internal factors, this project will increase our understanding of the fundamental processing underlying healthy sensory experience. The outcomes of this project will shed the light on new approaches and paradigms to investigate pathological conditions.